ULTRAFAST ANISOTROPY OF LIGHT HARVESTING COMPLEXES

The determination of ultrafast anisotropy changes can be of great value in determining how energy flows between different cofactors in an assembly. The techniques of anisotropy measurement need to be significantly refined in order that coherent and orientational aspects of energy transfer can be determined with high accuracy. The light harvesting complex is a perfect test example for this technology which is being developed (see Highlights for status of applications to light harvesting complexes).